THE AGE-RELATED EFFECT OF THE SWEET TASTE IN THE RAT

The long-term objective of this research is to develop an animal model for the study of age-related decrements in the sense of taste. There currently exists a paucity of research on changes in taste as a function of aging in all sub-human species, and, indeed, there is little known about such changes in humans. The specific aim of this project will be to study age-related changes in the sweet taste in the Fischer 344 rat. Since it has been shown that aged humans exhibit significant decrements in sweet sensitivity, the tastants to be used in this project will be sucrose, saccharin and glucose + saccharin mixtures. The Fischer 344 rat was chosen because of the extensive literature on all aspects of aging, particularly pathology, which is available for this strain. Both cross sectional and longitudinal studies will be conducted using rats from 150 to 900 days of age. Taste perception in the rat will be measured in two ways: 1. Detailed records of licking and drinking bouts together with day-night fluid and food consumption will be made on a 24-hr basis using a computer-monitored living cage. 2. Short-term drinking tests will be conducted with rats which have been implanted with a gastric cannula. This will allow for sham feeding tests where only oropharyngeal factors will operate since no postingestinal feedback is possible. These sham feeding rats can be used as their own controls in subsequent short-term drinking tests where the screw which closed the cannula is left in place. The age-related changes observed in the rat model will contribute to the understanding of the known decreases in taste sensitivity in the elderly human. These age-related taste changes undoubtedly contribute to the frequent loss of palatability and subsequent nutritional deficits in the older person.